Clinical Trial Readiness for K channel inhibitors in Cantu Syndrome

PROJECT SUMMARY Cantu syndrome (CS) is a rare genetic condition for which there is currently no directed therapy. CS patients suffer from multiple pathologies, but cardiovascular complications, and neurological features are major concerns. CS results from gain-of-function mutations in two specific genes that encode cardiovascular ATP-sensitive (KATP) channels. FDA-approved blockers of these channels are potential treatments. In preparation for a clinical trial, this project will validate cardiovascular and neurological features as markers of disease in a unique cohort of CS patients, and will validate KATP channel inhibitors as appropriate therapy in unique animal models of CS and in patient-derived cells. Successful accomplishment of the project will complete clinical trial readiness for the proposed therapeutic approach.

Public health relevance
NARRATIVE Cantu syndrome is a very rare disease, with multiple debilitating cardiovascular and neurological features, and for which there is currently no specific therapy. We are carrying out studies on Cantu syndrome patients to validate measures of the disease features, and in animal models to test a potential treatment, in preparation for a trial of the therapy in patients.